(1/2) Ponce Health Sciences University-Moffitt Cancer Center Partnership

PROJECT SUMMARY/STATEMENT
The Ponce Health Sciences University (PHSU) and the Moffitt Cancer Center (MCC) have forged a strong
working relationship founded on seamless communication with mutual support and benefits. With Partnership
resources and significant commitment from both institutions, we have established joint programs enhancing
basic and clinical research, enriching cancer outreach, expanding cancer education, and creating a unique
Hispanic/Latino (H/L) Biobank, leading to the development of a robust network and infrastructure necessary for
a sustained long-term collaboration to improve cancer outcomes in the H/L population. The U54 Partnership’s
impact includes the identification of new mutations in breast and lung cancer in H/L patients, recruitment of new
faculty at PHSU and MCC, 184 community outreach educational activities for H/Ls in Florida and Puerto Rico,
240 trainee participants, 234 peer-reviewed manuscripts, and 90 grants funded out of a total of 237 submitted.
Twenty Early-Stage Investigators have been supported by the Partnership. The development of the Puerto Rico
BioBank (PRBB), the Quantitative Sciences Core (QSC), as well as the training of clinical researchers and the
implementation of a clinical trial office at PHSU, demonstrate the broad impact realized through the Partnership.
Furthermore, the Partnership had a critical role in the ACGME re-accreditation of the Hematology/Oncology
Fellowship in PR, in the establishment of two stem cell transplant programs in PR by fellows trained in the MCC
Bone Marrow Transplant unit, and in the establishment of an ACGME-accredited surgical residency in Ponce
with surgical oncology rotations at MCC. Our vision for the U54 PACHE is to further grow and engage faculty
and students in cancer medicine research that directly impacts the H/L population in FL and PR. The Partnership
has the requisite components to fully execute this vision in an underserved population – a biobank, a quantitative
sciences core (QSC) to analyze data, culturally sensitive outreach materials, expertise in the latest technologies,
and a robust research portfolio. The bridge funding will facilitate continued sustainability of this Partnership.
The four specific aims proposed in the currently funded U54 Partnership grant are: Aim 1 – To Increase the
number of researchers at PHSU focused on basic/translational research in cancer and to augment the number
of researchers in cancer health disparities at MCC. This is facilitated with joint projects in ovarian and breast
cancer. Aim 2 – To further develop outreach programs and research efforts in H/L communities at both PHSU
and MCC. An epidemiological project will examine the impact of receipt of MC1R genotypes on personal sun
protection behaviors. Aim 3 – To increase support for basic, translational, and clinical research in the H/L
population by establishing the QSC and further developing the PRBB. The MCC Total Cancer Care protocol will
be developed in Ponce hospitals and leveraged by the PRBB to facilitate tissue collection. Aim 4 – To provide
comprehensive and structured student research education at both PHSU and MCC to facilitate the expansion
and success of cancer researchers and clinicians in the H/L population.

Public health relevance
PROJECT NARRATIVE Over the last 16 years, the Ponce Health Sciences University in Puerto Rico and the Moffitt Cancer Center in Florida have developed an exceptionally strong working relationship facilitated by the U56 Partnership Planning and U54 CPACHE (Type I and Type II) awards. The joint programs have resulted in successful outcomes in basic, translational, population and clinical research, as well as in community outreach, research education and training, biobanking and quantitative sciences. During the bridge funding period, efforts will focus on the continued growth, development, and sustainability of the Partnership while we submit our competitive renewal application.